The Development and Evaluation of a Culturally Grounded ENDS Intervention for Rural Hawaiian Youth

PROJECT SUMMARY/ABSTRACT
Since 2017, there has been an exponential growth in youths’ use of electronic nicotine delivery systems
(ENDS), both nationally and in the state of Hawai‘i [1, 2]. Recent surveillance data has indicated that 18% of all
middle school youth in the state of Hawai‘i currently use an electronic vapor product, ranking first nationally
among all states collecting data on middle school youth [1]. Of these youth, 30% are of Native Hawaiian or
Pacific Islander ancestry, representing the highest percentage of ENDS use among major ethnic groups in
Hawai‘i. Despite these alarming trends, there have been no ENDS prevention programs developed and
evaluated for youth in Hawai‘i or for Native Hawaiian youth [3]. Therefore, the purpose of this research
proposal is to develop and evaluate a culturally grounded, ENDS prevention intervention for rural Hawaiian
youth. This will be accomplished through two specific aims. AIM 1 (Years 1-3) are focused on pre-intervention
and intervention development. In Year 1, youth focus groups will be conducted to assess the environmental
demands related to ENDS use in rural Hawai‘i. In Year 2, specific ENDS-related problem situations (i.e.,
situations that increase risk for ENDS use) will be extracted from the Year 1 focus groups and prioritized
through survey methods with 200-250 predominately Native Hawaiian youth across 16 different
middle/intermediate schools on Hawai‘i Island. In Year 3, five situations found to be the most frequently
experienced and/or difficult to manage by youth surveyed in Year 2 will serve as the foundation for the
development of narrative scripts. Three of these scripts will be cast and filmed on location on Hawai‘i Island by
a professional film director, and will be edited into three short films, 6-8 video clips, and 6-8 professional
photos or production stills. Similar to our prior drug prevention research in rural Hawai‘i [4], classroom-based
lessons will be created to support the short films. Additional lessons and videos from an evidence-based,
culturally grounded substance abuse prevention curriculum for Hawaiian youth (Ho‘ouna Pono) [5] will be
used to create a modular classroom curriculum. The video clips and professional photography/production stills
will be embedded with prevention messaging, and will be used for a social and print media campaign to
reinforce the classroom curriculum. AIM 2 (Years 4-5) is to evaluate the ENDS prevention intervention
(classroom curriculum plus social/print media campaign) across all middle/intermediate public or public-
charter schools (N = 16) and up to 11 different cultural immersion charter schools on Hawai‘i Island using a
dynamic wait-listed control group design [6].

Public health relevance
PROJECT NARRATIVE In recent years, there has been an exponential growth of youths’ e-cigarette use nationally and in the State of Hawai‘i [1, 2], which has been associated with adverse health consequences, such as e- cigarette/vaping-associated lung injury (EVALI), susceptibility to COVID-19 [2, 7], and asthma [8]. In Hawai‘i, 30% of current e-cigarette users in middle/intermediate school are of Native Hawaiian or Pacific Islander ancestry, representing the highest percentage of users in this age group among the major ethnic groups in Hawai‘i [1]. This study actively engages rural communities in the development and evaluation of a culturally grounded e-cigarette/vaping prevention intervention for Hawaiian youth, complementing existing population- based efforts to address the e-cigarette epidemic affecting the State of Hawai‘i and Continental U.S.